Investigating Mechanisms of Isoleucine Restriction as an Effective Geroprotective Interventions

PROJECT SUMAMRY
The pursuit of an effective geroprotective strategy has been a critical goal for aging research since it has
became clear that the rapidly graying population will otherwise generate an unbearable socioeconomic strain.
Caloric restriction (CR) is an effective dietary intervention for healthspan and lifespan extension. Recently, other
dietary interventions have been developed as means to improve health and extend lifespan that may be more
sustainable than CR. Amongst these is protein restriction (PR), a dietary regimen that also boasts significant
metabolic, health, and longevity benefits in diverse species. The Lamming Lab has investigated the role of
individual essential amino acids in the effects of PR. Restriction of the branched chain amino acids (BCAAs;
leucine, isoleucine, valine) was found to recapitulate the many metabolic benefits of PR, and extends lifespan in
male mice when the dietary intervention was lifelong. Further study has found the restriction of isoleucine (Ile) to
be both necessary and sufficient for the metabolic benefits of PR. In preliminary experiments, isoleucine
restriction (IleR) in young adult mice improves glycemic control, reduces adiposity, and, in males, delays age-
related increases in frailty and extends lifespan.
In this proposal, I will first determine if IleR can effectively promote healthy aging when started in late-life.
I will examine how IleR affects metabolic health, physical performance, frailty, and lifespan. We have found that
IleR induces ketogenesis: the production of the ketone body β-hydroxybutyrate (BHB), which has been shown
to have geroprotective properties. In fact, a ketogenic diet has been shown to extend mouse lifespan. In the
second aim of this proposal, I will investigate the role of ketogenesis in the metabolic benefits of IleR using mice
with the conditional deletion of Hmgcs2, the rate-limiting enzyme for ketogenesis, in the liver. In the final aim of
this proposal, I will leverage pharmacological and viral approaches to manipulate the catabolic flux of BCAAs to
test the hypothesis that increasing BCAA catabolism can simulate the effects of IleR by reducing the standing
pool of BCAAs. These experiments will enable us to determine whether the reduction of Ile itself, or of its
catabolites, are responsible for the beneficial effects of IleR, and demonstrate if the manipulation of BCAA
catabolic flux can be a viable geroprotective strategy.
The overarching goal of this proposal is to further define the effects and identity of the molecular
mechanisms underlying the benefits of IleR. The extensive investigation described here represent the perfect
project for my growth as a trainee and will push forth the development for a feasible, highly effective, and
metabolically focused geroprotective strategy.

Public health relevance
PROJECT NARRATIVE Aging is a primary risk factor driving many debilitating diseases, and the development of an efficacious and readily sustainable healthspan-extending strategy is paramount to the wellbeing of our rapidly graying population. Dietary interventions are a proven metabolically targeted approach that engages innate biological pathways to induce powerful geroprotective effects. Herein, we will investigate the effects and molecular mechanisms of isoleucine restriction, which is a recently discovered, highly effective dietary intervention, dissecting several of its mechanistic connections and pursuing novel treatment strategies that could potentially recapitulate its beneficial effects.